CK22-005, Pacific Southwest Center of Excellence in Vector-Borne Diseases

PROJECT SUMMARY
The Pacific Southwest Center of Excellence in Vector-Borne Diseases (PacVec) offers an opportunity to address an
urgent and compelling public health challenge—the ongoing rise in vector-borne diseases, particularly those
transmitted by mosquitoes and ticks—by leveraging the resources of seven leading research and teaching
institutions that have well-established partnerships with a strong cadre of mosquito control and public health
agencies around our region. Vector-borne diseases have been increasing in prevalence in the U.S., emerging at a
frequency higher than that of other infectious diseases. The impact of this trend is keenly felt in the Pacific Southwest
and our US-affiliated Pacific Islands, with our large and diverse population and our position as a global hub for travel
and commerce. Many of our public-health and vector-control partners are also national leaders in terms of expertise
and resources to combat vector-borne diseases, and PacVec presents an excellent opportunity for knowledge
exchange and capacity strengthening through sharing of knowledge across our community of practice and through
collaboration with other CoEs.
PacVec seeks to build on our successful efforts of the last five years to continue to expand local communities of
practice throughout the Pacific Southwest and US-affiliated Pacific Islands. We plan to conduct a wide range of
research projects to rigorously evaluate both new and existing methods to prevent tick- and mosquito-borne
diseases, and to engage and train a culturally diverse workforce reflective of the racial and ethnic diversity of the
region and knowledgeable in their respective fields (e.g. public health, vector control, entomology). Our plans have
been developed through constant engagement between PacVec’s Leadership Team and our public health and vector
control partners throughout the region to address our most pressing vector-borne disease needs.

Public health relevance
PROJECT NARRATIVE The Pacific Southwest Center Excellence in Vector-Borne Diseases (PacVec) offers an opportunity to address an urgent and compelling public health challenge—the ongoing rise in vector-borne diseases, particularly those transmitted by mosquitoes and ticks—by leveraging the resources of seven leading research and teaching institutions that have well-established partnerships with mosquito control and public health agencies around our region. Together, we propose a center that is responsive to and reflective of the needs of the broader US Southwest population, with applied research to advance methods to prevent the spread of vector-borne diseases and to train a culturally diverse “community of practice” including public-health scientists and other professionals.